Rhode Island IDeA Network for Excellence in Biomedical Research

Project Summary for Developmental Research Project Program (DRPP) Core
The overarching goals of Rhode Island-IDeA Network of Biomedical Research Excellence (RI-INBRE) are to
enhance the biomedical research capacity of the program institutions and to facilitate mentored experiential
research opportunities for students. The major function of the Developmental Research Project Program (DRPP)
Core (“Projects Core”) is to design and oversee several competitive funding mechanisms in the RI-INBRE
thematic areas of cancer, neuroscience, and environmental health science. The Projects Core implements four
primary funding mechanisms designed to meet the varying research needs and career stages of participating
investigators at URI/Brown and the partner primarily undergraduate institutions (PUIs). These include 1) Early
Career Development (ECD) awards for junior faculty at URI/Brown and the partner Rhode Island PUIs; 2)
Collaborative Research (CR) awards for junior faculty at the PUIs who collaborate with a senior investigator(s)
at URI/Brown; 3) Pilot Project (PP) awards for investigators at the network institutions; and 4) Summer
Undergraduate Research Fellowship (SURF) awards for faculty of all levels at the PUIs. Several new initiatives
are planned for the renewal period including extending the duration of the ECD mechanism from two to three
years; implementing mentored training for all project investigators; expanding the scope of the PP mechanism
to include faculty at all career stages at URI/Brown and the PUIs and to include projects focused on community
engagement and outreach activities. By implementing these strategies, we will continue to serve as a catalyst
for biomedical research career development and fuel economic development in the biotechnology,
pharmaceutical, and life sciences industries in the State of Rhode Island.

Public health relevance
Narrative for DRPP Core is not applicable.